Adaptations and Impacts Understanding Teen Pregnancy Prevention Programs

Adaptations & IMpacts – Understanding Teen Pregnancy Prevention Programs (AIM-UP)
Abstract:
Adolescent pregnancies remain an area of marked health disparities, with significantly higher
rates among Black and Latino/a populations, rural youth, and youth involved in systems. What
there has been significant effort put into the initial development and testing of evidence-based
teen pregnancy prevention programs (EBPs), little data exist to guide replication and adaptation
to local contexts or for diverse populations. Yet most programs require some type of
adaptation. The AIM-UP project combines mixed methods data from nine large-scale federal-
and state-funded replication projects with over 17,000 participants from diverse locations and
populations across the state of Indiana. The AIM-UP project seeks to advance our
understanding of adaptation in EBPs focused on four key areas: system involvement and
trauma, implementing in rural communities, diversity, equity, inclusion and justice, and the need
for virtual learning approaches. Using the Framework for Reporting Adaptations and
Modifications-Expanded (FRAME) as a guide, the specific aims of this proposal are: (1) to
describe the frequency, characteristics and type of adaptations made when implementing EBPs
with a focus on the above four key areas; (2) to quantitatively examine the effect of adaptations
in these four key areas on key EBP targets, including skills, knowledge, attitudes, intentions and
behaviors, using youth surveys; (3) to describe stakeholder's approaches for determining the
need for adaptations for trauma/system involvement, DEIJ, rural delivery and virtual delivery,
processes of adaptation, and assessment of adaptation impact; and (4) to create an adaptation
toolkit using a Delphi process involving expert and community stakeholders. The AIM-UP
Project team is a 10 year university-community collaboration, led by Dr. Mary Ott, and
supported by Dr. Devon Hensel and Health Care Education and Training, Inc. (HCET). The
team has the research and analytical experiences, collaborative history, project management
skills, and program implementation expertise necessary to execute the proposed study. The
AIM-UP Project will inform EBP adaptation and replication.

Public health relevance
AIM-UP Narrative: AIM-UP will combine data from nine large-scale teen pregnancy prevention projects to describe the use, examine the effectiveness, and describe approaches to adaptations of evidence-based programming for four youth at high-risk for unintended pregnancy. Using the FRAME framework, the project examines adaptations in the following four areas: (1) trauma and system involvement; (2) diversity, equity, inclusion and justice; (3) implementing in rural communities; and (4) adapting for virtual delivery. Effective adaptations will be translated into a toolkit using the Delphi approach for adapting evidence-based programs to local contexts.